Project 1

PROJECT SUMMARY
Germline pathogenic variants (PV) in the BRCA1, BRCA2 and PALB2 cancer predisposition genes are associated
with high risks of breast cancer (lifetime risks to age 80 of >50%), whereas PVs in ATM and CHEK2 are associated
with moderate lifetime risks of 20-25%. Of these, PVs in ATM, BRCA2, CHEK2 and PALB2 are predominantly
associated with estrogen receptor positive (ER+) breast cancer. While much is known about ER+ breast cancer
overall, little is known about the contribution of PVs in these predisposition genes to ER+ breast cancer risks and
to the influence of these PVs on prognosis. Here we aim to address some of the important clinical questions that
remain unanswered for these ER+ breast cancer predisposition genes. In Aim #1 we propose to assess age-related
risks of cancers associated with ER+ breast cancer predisposition gene PVs. Specifically, while overall risks of
breast cancer are well established, age-related risks of breast cancer in 5-10 year categories and risks of
contralateral breast cancer are not known for the ATM, CHEK2 and PALB2 genes. In the absence of this
information the overall risks of cancer associated with PVs are of limited clinical value. We will use information from
very large population-based including targeted studies of African Americans and West Africans and from high-risk
breast cancer studies to estimate these cancer risks. In Aim #2 we propose to establish the influence of PVs in ER-
positive breast cancer predisposition genes on prognosis. It is not currently known whether breast cancers driven
by ER+ predisposition genes, other than BRCA2, display specific responses to standard therapy (such as
chemotherapy, endocrine therapy or HER2 directed therapy). We propose to screen germline DNA from
participants in large breast cancer adjuvant clinical trials for PVs in the ER+ breast cancer predisposition genes
and to assess the influence of PVs on disease free survival and overall survival in response to adjuvant therapy.
In addition, we will determine whether the PVs are correlated with the Oncotype Dx Breast Recurrence Score,
which is an effective prognostic and predictive biomarker for ER+ breast cancer patients. In Aim #3 we propose to
determine the clinical relevance of Variants of Uncertain Significance (VUS) in ER-positive breast cancer
predisposition genes. Individuals carrying germline VUS, which are predominantly missense variants, cannot
benefit from enhanced risk assessment and cancer screening or make informed decisions about surgical
prevention or screening. We will conduct individual and high-throughput functional assay studies and apply rules-
based FDA-approved ClinGen methods for determination of the clinical relevance of many VUS in these genes.

Public health relevance
PROJECT NARRATIVE The risk estimates for primary and contralateral breast cancers associated with pathogenic variants (PVs) in estrogen receptor positive breast cancer predisposition genes for women of all ages from the general population and high-risk population will substantially improve risk assessment and management of these individuals. Reclassification of variants of uncertain significance in these genes as pathogenic or benign will also improve the utility of genetic testing results. Furthermore, determination of the influence of PVs in ER-positive predisposition genes on disease free survival and overall survival in response to adjuvant therapy and whether these PVs are correlated with Oncotype Dx Breast Recurrence Scores will provide substantial insight into the selection of therapy for women with PVs in these genes.